Core A - Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE (CORE A)
In this competing renewal P01 application, the Administrative Core (Core A) will continue to provide critical
centralized grant administration, data processing, communication, and budget management for all the projects
and cores. This Core will also serve to amalgamate the investigators, their experimental findings and their
ideas, evaluation of research efforts and critically direct the summary efforts toward maintaining a highly
integrated program outcome. The Specific Aims of Core A are to: 1). Provide administrative services to the
investigators. This includes the management of project supplies, filing, development of memos, meeting
minutes and communications covering all operations, including publications; 2). Organize Program-related
meetings. Organize monthly or bi-monthly meetings/conferences of all P01 investigators; quarterly meetings
of the Program Steering Committee; annual meetings of the Scientific Advisory Board 3). Maintain program
integration activities. These include data sharing, rapid publication efforts, and identify and institute other
novel activities critical to maintaining and strengthening the integration of the program. 4). Provide overall
fiscal review, accounting, and real time budgets analyses. This includes reports, verbal communications,
reviews and forward-looking projections on expenditures. This Core is essential for maintaining a highly
integrated program and effective communication of the P01 program.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE (CORE A) The primary objectives of the Administrative Core are to provide overall administrative and fiscal support to all of the Projects and Cores of this Program Project focused on the discovery and development of novel antibody therapies and theranostics for the treatment and diagnosis of solid tumors. This Core will serve as the communication hub for the Program Project and is essential to the success of the investigations proposed in this P01.